Vector and Transgenic Mouse Core

The overall objective of the Vector and Transgenic Mouse Core is to provide Diabetes Research Center
affiliate investigators at the University of Washington and the Greater Seattle area with state-of-the-art vectors
necessary to overexpress, knockdown, knockout, edit, or otherwise alter expression of RNAs and proteins of
interest in cultured cells, isolated tissues, and animals. The Core has considerably evolved since the last
competitive renewal. New services provide CRISPR (clustered regularly interspaced short palindromic
repeats)/Cas9 vectors, reagents and methods to identify edited genes have been added, and the number of
viral vector serotypes available has been greatly expanded. These newer services are highly used, and now
provide the bulk of the Core's work. Conversely, services that are less cutting-edge and are no longer
frequently requested have been removed. The specific aims of the Core are to provide the following services to
affiliate investigators: (1) Production of adeno-associated viral vectors (AAVs), lentiviral vectors, foamy virus
vectors, and gammaretroviral vectors for use in animals, tissues and cells; (2) Genome editing (editing, knock-
out, knock-in) in cells and mice by CRISPR/Cas9; (3) Cost-effective production of genetically engineered mice
by CRISPR/Cas9 and cryopreservation through the University of Washington Preclinical Research and
Transgenic Services; (4) Screening and analysis of effects of gene editing by molecular biology techniques;
and (5) Consultation and training. The Core has been highly productive in the current funding period and has
added new services that are expected to significantly increase productivity and usability for Diabetes Research
Center affiliate investigators to meet the Center's goal to enhance research in diabetes, obesity and related
disorders in the Greater Seattle area and beyond.